Michigan Department of Health and Human Services Project A6. Food Defense Track Laboratory Flexible Funding Model Application

Project Summary:
The Michigan Bureau of Laboratories in partnership with FDA will maintain required aims for the Food
Defense Track. This includes attending of at least 2 key personnel LFFM annual face to face meetings
with oral and/or poster presentation, the maintenance of FERN membership (to include annual
membership veriﬁcation) maintenance of a valid 20.88 with FDA, maintenance of facilities and
personnel to ensure capacity, participation in routine track webinars and meetings, timely response to
inquiries from FDA/LFFM staﬀ, participation and successful passing of annual proﬁciency testing,
participation in small-scale method development, validation, and matrix extension works, support
overﬂow, emergency, surge capacity and other assignments in a ﬂexible manner to meet programmatic
needs and initiatives, maintenance of ISO17025 accreditation, provide training and mentorship to other
state laboratories, ensure methods utilized within the scope of the track are validations.

Public health relevance
Project Narrative: The Michigan Bureau of Laboratories in partnership with FDA through the Laboratory Flexible Funding Model, will provide testing capabilities and capacity to support national food defense public health surveillance and response initiatives that are needed for the detection of microbiological contamination within human and animal food sources.